Postpartum regulation of CRFR1 and CRFR2 expression in oxytocin neurons

Project Summary
Psychological stress can profoundly impact maternal care and is associated with mental illnesses including
postpartum depression and anxiety. Approximately 900,000 women suffer from postpartum depression and
anxiety annually, resulting in devastating effects on the mother and developing child. Both oxytocin (OT) and
corticotropin releasing factor (CRF) have been implicated in stress-related behavioral changes during the
postpartum period. However, the precise mechanisms that control these changes, and the mechanisms through
which the OT and CRF systems might interact to control behavioral changes, are largely unknown. We recently
discovered that OT neurons of the mouse hypothalamus initiate expression of a receptor for CRF (CRFR1)
during the postpartum period, whereas CRFR1 is absent from OT neurons in virgin mice. Our preliminary studies
indicate the postpartum expression of CRFR1 in OT neurons modifies maternal care behaviors under conditions
of stress. Our recent findings further suggest that the other primary receptor for CRF (CRFR2) also increases in
OT neurons during the postpartum period. One critical issue that remains unknown is the factors that cause OT
neurons to express CRF receptors. Therefore, the primary goal of this proposal (Aim 1) will be to determine the
precise hormones and/or maternal experiences that induce this change. Specifically, we will treat virgin mice
with pregnancy/postpartum period specific cocktails of estrogen/progesterone, prolactin, and glucocorticoids to
determine the critical hormones that initiate CRFR1/CRFR2 expression in OT neurons. We will also determine
whether specific experiences, including nursing and maternal care, can induce CRF receptor expression in OT
neurons. Overall, experiments in Aim 1 will generate new hypotheses regarding the mechanisms through which
dramatic maternal fluctuations in hormones and maternal experiences might impact the maternal brain and
ultimately affect behaviors related to stress. In the second (smaller) aim we will perform a study to determine
how expression of CRFR2 in OT neurons changes during the postpartum period. We recently found CRFR2
levels increase within OT neurons at a single timepoint (postpartum day 7) but how CRFR2 changes across the
maternal period and whether these changes coincide temporally with alterations in CRFR1 is unknown.
Therefore, this study will allow us to determine how (a) CRFR2 levels change across the postpartum period in
mice and (b) whether CRFR2 and CRFR1 are present within the same OT neurons or in different subpopulations
of OT neurons. These findings will be critical given that CRFR1 and CRFR2 commonly have opposing roles in
regulation of stress responses and maternal behaviors. Thus, a shift in the balance of these two receptors could
have profound impacts. Overall, experiments in this R03 proposal will aid in our understanding of neurobiological
changes that occur during the maternal period and are associated human disorders including postpartum
depression, anxiety, and poor parental care.

Public health relevance
PROJECT NARRATIVE Oxytocin has been hypothesized to play a critical role in regulating changes in stress-related behaviors during the maternal period, although the neurobiological mechanisms of these actions are unclear. We recently discovered that oxytocin neurons express corticotropin releasing factor receptor 1 (CRFR1; a receptor known to regulate stress) only in mice that have given birth, suggesting this may be a key mechanism by which oxytocin neurons receive stress signaling during the maternal period. We will perform experiments to determine the hormones and experiences that induce these changes and also determine how expression of a related stress receptor (CRFR2) is altered within oxytocin neurons during the maternal period.